Wilmer Eye Institute Stimulating Access to Research in Residency Program

PROJECT SUMMARY
The Johns Hopkins Wilmer Eye Institute StARR (Stimulating Access to Research in Residency) Program
seeks to extend its goal of training clinician-scientists in the areas of clinical and laboratory vision research.
The program has 4 goals: 1) recruitment of qualified resident-researchers (scholars) with an interest in
studying ocular disease, 2) optimizing the research experience of accepted scholars, 3) preparing scholars for
successful clinician-scientist careers, and 4) ensuring successful clinical and surgical training. Recruitment will
be facilitated by Wilmer's strong research presence, including over 50 active scientists serving as program
faculty with combined annual funding over $30 million, more than any other ophthalmology department. Wilmer
scientists work across all core NEI programmatic areas, and benefit from several research-focused Centers
housed within Wilmer or the Johns Hopkins Medical campus. The facilities and resources enabling Wilmer's
clinical and lab research program are unsurpassed, including the 200,000 sq ft Smith Building, active T32 and
P30 grants, and 66 endowed professorships. Wilmer has produced more full-time academics and Department
Chairs than any other eye department in the U.S. Wilmer has a strong program training and mentoring
clinician-scientists as part of its K12 program, as well as its Rising Professorship program for junior faculty.
Additionally, Wilmer provides, and will extend, its resources to residents pursuing research, including grants
and endowed support to reward top research. Our program will ensure scholar success by helping them plan
their research and overseeing progress via an Advisory Committee of R01-funded scientists, K awardees, and
residency leadership. Unique program features include having scholars prepare career development and
research plans, which will be reviewed, revised, and approved prior to starting research. The Committee will
also ensure progress through semi-annual reviews (written and joint scholar/mentor meetings), written reports
with recommendations, and scheduled check-ins. Resident researchers will be prepared for long-term success
via training activities including journal clubs and workshops on manuscript writing, grant writing, and career
development. Long-term research scholar success will be aided by Advisory Committee reviews beyond the
end of the dedicated research period (including a review of drafted K award aims, which will be required from
scholars) and formal evaluation for burnout. Finally, StARR residents will have their clinical progress carefully
monitored to ensure that they are meeting all clinical milestones, and that research excellence is matched by
excellence in clinical and surgical skills.

Public health relevance
PROJECT NARRATIVE The Wilmer Stimulating Access to Research in Residency (StARR) program creates a pathway for residents interested in pursuing research during residency to build their skills through mentored research conducted within a Wilmer Ophthalmology residency. Wilmer StARR residents will conduct 1-2 years of dedicated research, with research preparation and progress actively monitored and guided by Executive and Advisory Committees. Clinician scientist training will be supplemented by dedicated workshops on manuscript writing, grant writing, and career development.